Mechanisms underlying gastric intestinal metaplasia and carcinogenesis

PROGRAM SUMMARY
Gastric cancer or GC (inclusive of gastroesophageal junction cancers) is the 5th most frequently diagnosed
cancer globally. Significant variability in gastric cancer incidence and mortality has been reported between
racial/ethnic groups. In the U.S., non-Hispanic Blacks (NHB), Hispanics (USH), and non-Hispanic Asian or
Pacific Islander (NHAPI) are more commonly diagnosed with gastric cancer and have higher mortality compared
to Non-Hispanic Whites (NHW). Intestinal metaplasia (IM) is a key precursor to GC with an intermediate stage
of dysplasia. Gastric IM tends to be present at the antrum-corpus junction, particularly at the incisura angularis;
gastric IM can also arise in the cardia. Factors that contribute to the development of gastric IM include bile reflux
cigarette-smoking, alcohol, high salt intake, and H. pylori infection. A hallmark of IM in both the stomach and the
esophagus (=Barrett’s esophagus) is the change of cellular identity to a columnar intestinal type of epithelium,
suggesting that IM has shared mechanisms across these two organs. Several key transcription factors like CDX2
are functionally required to initiate IM, perhaps in concert with other factors and involving epigenetic
reprogramming. The main goal of our proposed studies is to resolve fundamental gaps in the field (1) How does
gastric IM arise? (2) Is there a common molecular pathway initiating IM in the gastric cardia and antrum? (3)
How do TP53 tumor suppressor gene mutations and inflammatory cues each contribute to the initiation of IM?
We will employ complementary, innovative platforms inducible pluripotent stem cells (iPSC) models, 3D
organoids from patients with gastric IM, and co-culture of these organoids with fibroblasts and immune cells to
decipher how microenvironmental cues catalyze the transition from metaplasia to dysplasia and GEJ/gastric
adenocarcinoma. We seek to understand how ethnicity may play a role in the pathogenesis of gastric IM as that
might reveal new insights and address health care disparities through our multi-institutional consortium
(Cincinnati Children’s Hospital, Columbia University, and University of Puerto Rico). We will test the hypothesis
that cell autonomous and non-cell autonomous mechanisms underlie the formation of gastric IM, dysplasia, and
carcinoma through the following interrelated Specific Aims: Aim 1: To identify the molecular basis of
gastric IM using inducible pluripotent stem cells (iPSC); Aim 2. To elucidate how TP53 mutations and
inflammatory cues contribute to the initiation of IM and/or the progression to dysplasia and cancer.
Characterization of gene expression, transcriptional regulation, and chromatin accessibility will be invaluable to
identify putative targets to prevent and/or treat gastric IM/dysplasia.

Public health relevance
PROGRAM NARRATIVE Gastric cancer is common globally. We seek to develop and characterize model systems (iPSCs, organoids) to reveal how gastric intestinal metaplasia and dysplasia, precursors to gastric cancer, form. In so doing, we will unravel new insights into potential applications for prevention, early detection, screening and surveillance.